Core B: Flow and Mass Cytometry

Abstract/Summary
Core B: Flow and Mass Cytometry Core.
The progression of events leading to Type 1 is accompanied by alterations in multiple cell types and tissues.
Characterization, tracking and isolation of those cell populations are enabled by the instruments and expertise
available in the Flow and Mass Cytometry Core.
Purpose: The Flow and Mass Cytometry Core assists investigators with the characterization of molecular
markers in dispersed cells and/or the isolation of cells based on those markers through the following:
1. Flow Cytometry. Ten high-speed, multi-laser flow cytometers and analysis programs with highly
complementary capabilities are available to meet DRC demand for cell characterization.
2. Mass Cytometry. Two CyTOF-Helios mass cytometers are available to meet DRC demand for high-
dimensional cell characterization. The recently installed MIBIscope also enhances high-parameter
imaging demands from the user base.
3. Cell Sorting. Nine high-speed, multi-laser fluorescence activated cell sorters enable DRC investigators
to isolate cell populations that can then be extensively characterized molecularly or that may be re-
introduced to host animals to examine the effect of those cells on disease progression.
4. Information and Training. The Core trains investigators on the proper use of equipment, and provides
consultation and advice on the application of the technology.
5. Operator Assistance. For researchers who would prefer to have an experienced flow cytometrist sort or
analyze for them, the Core provides this key service upon request. In such cases, a staff member will
be at a specific instrument and run samples for the researchers.
6. Analysis workstations loaded with software for conventional and high dimensional analysis.
Benefits to DRC Community: The Core accelerates diabetes research by providing DRC investigators with
access to advanced technologies and operational expertise beyond the reach of most individual labs. During the
last funding period of this grant (2015-2020), DRC investigators logged an average of 14,000 hours of usage per
year. Moving forward, 31 DRC members, with grants totaling more than $13.9M in annual direct costs for
diabetes-related research would benefit from funding this Core.
Technology Development: DRC support enables dedicated time and effort on development projects for advanced
capabilities that accelerate research for DRC investigators.